Shared Resource Management

SHARED RESOURCE MANAGEMENT
PROJECT SUMMARY/ABSTRACT
The central goal of Shared Resource Management (SRM) is to ensure that the seven Shared Resources (SRs)
supported by the Chao Family Comprehensive Cancer Center (CFCCC) provide cutting-edge, cost-effective,
easily-accessible services that facilitate high-impact cancer research. CFCCC SR services span the spectrum
from patient-focused behavioral science to cellular and molecular aspects of cancer, providing high quality
services that operate at the leading edge of their respective disciplines. In support of these services, the CFCCC
provides financial support, management and oversight, ensuring that SRs offer state-of-the-art technologies,
services and consultation. In the current funding period, the CFCCC has provided $1.12M for equipment costs
alone. The overall total CFCCC contribution to support the SRs ($6.2M) was matched by institutional support
from UC Irvine (UCI; $4.30M).
The CFCCC directly manages one SR and jointly governs the other six with UCI academic units. Governance
mechanisms and ongoing monitoring are in place to ensure that SRs are adequately supported and that they
follow NCI guidelines for Cancer Center member accessibility, cost-effectiveness, and quality. The SRs are led
by CFCCC Deputy Director (DD) Marian Waterman, PhD, with leadership assistance from the Associate Director
(AD) for Administration & Finance Christine Hui, MPH. Together the DD and AD oversee and monitor the
development and effectiveness of technologies and services offered to CFCCC members. Waterman and Hui
are assisted by the ADs for Basic Science, Clinical Science, and Population Science & Cancer Control. The
SRM team works on behalf of CFCCC membership to ensure priority access to technologies, services, and
expertise that enhance scientific interaction and productivity; to monitor the stability, reliability, cost-
effectiveness, and quality of research resources; and to evaluate the scientific needs of cancer center members
and facilitate the development and/or purchase of new technologies, services and methodologies. During the
next funding period, the CFCCC plans to develop a new SR in Mass Spectrometry.

Public health relevance
SHARED RESOURCE MANAGEMENT PROJECT NARRATIVE Per PAR-20-043, a Project Narrative is not required for this component.